32nd International Workshop on Retroviral Pathogenesis

Project Summary/Abstract
The International Workshop on Retroviral Pathogenesis, now in its 32nd year, has long served as
a forum for the exchange of new research findings and concepts on all aspects of retroviral
pathogenesis from molecular mechanisms to the immunological parameters of host-virus
interaction. Unfortunately, due to the pandemic and the restrictions on international travel, it was
postponed in 2020 and 2021. The 2022 rescheduled conference will continue a tradition of
intimate, engaged scientific interaction on all aspects of retroviral pathogenesis with strong
emphasis on animal retroviruses as models for human disease. Retroviral pathogens of humans
and animals in all retroviral genera are the subject of scientific presentation and vibrant
discussion. Topics at the workshop will include retrovirus entry and integration, replication and
restriction, assembly, immune responses, oncogenesis, pathogenesis, new and emerging
pathogens, endogenous retroviruses, and animal models of disease. Approximately 100
participants are anticipated, including principal investigators, postdoctoral trainees and graduate
students. Planned for October 12-16, 2022 in Vail, Colorado, the small size and format of the
conference supports concentrated interaction and deep scientific engagement. The conference
fosters the professional development of junior investigators by affording them the opportunity to
present their current work to a panel of engaged colleagues and to serve as Session Chairs. The
overarching goal of the conference is to provide a forum that fosters continued scientific
engagement leading to innovative conceptual advances and research in the area of retroviral
pathogenesis, broadly defined. The conference will address this goal through three specific aims:
(1) Bring together national and international scientific leaders in the field, together with junior
investigators, postdoctoral and student trainees; (2) Provide opportunities for five invited keynote
scientific presentations and discussions as a group, interspersed with more intimate opportunity
for discussion and interaction; (3) Provide platform opportunities for junior investigators, women
and underrepresented minority scholars through scientific presentation and/or designation as
Session Chairs; and (4) Provide Writing Workshop covering topics such as how to frame
research findings for publication, the steps a manuscript goes through in the editorial process,
the mechanics of writing and research and publication ethics.

Public health relevance
Project Narrative Retroviruses have long been recognized as important pathogens of humans and animals, and research on these agents has uncovered important discoveries in cell biology and mechanisms in human disease. The 32nd International Workshop on Retroviral Pathogenesis will continue a long tradition of intimate, engaged scientific interaction on all aspects of retroviral pathogenesis with strong emphasis on animal retroviruses as models of human disease. The conference will convene national and international scientific leaders in the field, together with junior investigators, postdoctoral and student trainees, for scientific presentation and engaged discussion.